Manufacturing Process for Ultra-Thin, Ultra-Reliable, and Implantable Liquid-Crystal-Polymer-Based Bioelectronic Interfaces

PROJECT SUMMARY:
This proposal seeks to serve the needs of patients that require high-electrode-density neural interfaces that are
extremely flexible, cause minimal tissue response, and function for the life of the patient. Clinical applications
include high-channel-count brain-machine interfaces (BMI) to restore sensory and motor function, high-channel-
count nerve interfaces for sensing and controlling state-of-the-art prosthetics limbs, next-generation deep-brain
stimulation (DBS) systems, and many others. We propose to overcome this longevity barrier by significantly
advancing the manufacturing processes used to produce implantable thin-film neural interfaces based on liquid
crystal polymers (LCP), which when used in a thick-film form have demonstrated exceptional robustness and
reliability. The work proposed is focused on significantly improving LCP-based neural-interface technology in
two innovative and independent ways. First, in Aim 1 we will develop a microfabrication process that can produce
bonded multi-layer LCP-based devices that are at least 5X thinner than possible with today's manufacturing
processes (i.e.,  10 μm compared to  50 μm) without compromising the strength of the bond between the LCP
layers and between the LCP layers and a metal layer. Second, in Aim 2 we will develop a manufacturing process
that can produce metal features on highly roughened LCP that are 10X thinner (i.e., 1 μm compared to >10 μm)
and 5X narrower (i.e., 5 μm compared to  25 μm) than demonstrated commercially with LCP today, and in a
manner that increases the bond strength of the metal layer to both LCP layers, increases electrical-isolation
reliability, and does not compromise electrical-conduction reliability. Much thinner and narrower interfaces have
been shown to cause far less adverse tissue response and should result in higher signal to noise ratio and interface
operational lifetime. To assess the material and electrical reliability of our much thinner and narrower LCP
interfaces, we will use aggressive RAA soak tests and statistically measure channel isolation and resistance as a
function of dielectric-layer parameters (i.e., layer thickness, roughness, bonding parameters, and other process
parameters) and metal-layer parameters (i.e., metal trace thickness, width, separation, length, and integration
method). We will compare results with implants produced using other thin-film polymer-metal neural-interface
technologies (e.g., polyimide) and commercial thick-film LCP.

Public health relevance
NARRATIVE: The proposed research will develop a neural interface technology that is ultra-reliable, yet thin, scalable, and robust. The lack of a high-channel-count and high-channel-density neural interface technology that can last the life of the patient, is impeding the broader clinical translation of new therapies that require such high- performance and long-lasting interfaces. The proposed research is relevant to the translational focus of the NIH’s mission and will potentially help to improve the quality of life and reduce the cost and burdens of human disability due to conditions that could be addressed with ultra-reliable high-channel-count bioelectronic implants.